In-vivo study of KSP/QRH heptapeptide dimer for detection of biliary intra-epithelial neoplasia

Project Summary
In this Direct to Phase 2 SBIR proposal, IVMT, LLC aims to perform a Phase 2 multi-center study to
advance the clinical utility of a targeted image contrast agent. This small business start-up has been formed to
commercialize highly sensitive cancer-specific imaging agents. A near-infrared (NIR) fluorescently-labeled
peptide heterodimer specific for EGFR and ErbB2 will be topically administered in the biliary tract to distinguish
the benign versus malignant etiology of indeterminant biliary strictures. Current methods used to image the
bile ducts can visualize non-specific anatomical features, but do not reveal the underlying molecular properties
that drive malignancy. The heterodimer is a novel biochemical structure that arranges two unique peptide
ligands that bind with high specificity to cell surface targets that stimulate epithelial cell growth, proliferation,
and differentiation. These targets are highly overexpressed by cancers that obstruct the biliary tract to form
indeterminant strictures. The peptide monomers are separated by a PEG linker with a unique length to match
the physiological spacing between the two targets to bind concurrently. This innovative configuration
generates synergistic target-ligand interactions that can substantially improve binding performance compared
with individual monomer peptides. Cancer is a heterogeneous process, thus the detection of multiple targets
may be needed to achieve optimal imaging performance. Quantified results from the peptide heterodimer
binding to transformed cells in vitro showed a substantial increase in fluorescence intensity by comparison with
that for either target individually, and the binding affinity was found to improve by >3-fold versus that of either
monomer peptide. Increased sensitivity occurs from simultaneous detection of two unique targets. Greater
specificity arises from the bivalent structure binding to a larger combined region of the target. Using this
approach, early targets can be detected at lower levels of expression, and may identify malignant biliary
strictures at an early stage. The specific aims are as follows. The IRDye800-labeled peptide heterodimer will
be synthesized using Good Manufacturing Practices, aliquoted in single use vials, and distributed to n = 6
clinical sites. Stability will be monitored over the duration of the study. A single IRB will perform ethical review
and regulatory oversight. The peptide heterodimer will be administered topically to at least n = 20 patients with
indeterminant biliary strictures at each site. NIR fluorescence images will be collected in vivo using a multi-
modal scanning fiber cholangioscope. A deep learning algorithm will be developed to evaluate the in vivo
images by calculating a target-to-background ratio from regions of NIR fluorescence. Clinical evidence will be
collected to demonstrate efficacy for a peptide heterodimer to distinguish malignant from benign indeterminant
biliary strictures in a diverse population and broad range of etiologies. A clinical network of academic medical
centers will be established over a national geographic distribution to perform the multi-center study.

Public health relevance
Project Narrative A multi-center clinical study will be performed to evaluate the effectiveness of a new image contrast agent to identify the cause of obstruction in the bile ducts using a flexible fiber instrument to visualize molecular targets expressed on the tissue surface that are specific for cancer.